Testing the feasibility and preliminary efficacy of a psychological and behavioral intervention to promote physical activity after weight loss surgery

PROJECT SUMMARY/ABSTRACT
Candidate. This administrative supplement will allow Dr. Feig to continue toward her path of becoming an
independent investigator with expertise in developing and testing evidence-based interventions to improve
health and well-being in patients with obesity. Her achievements thus far demonstrate her promise as a clinical
researcher (39 peer-reviewed publications), and with the additional training and mentorship she is receiving
through this K23 award she will contribute significantly to efforts to reduce the burden of obesity and improve
quality of life for those with obesity.
Training Plan. Dr. Feig will continue with her proposed training plan after her return from maternity leave,
which will be possible with the additional support that will free up for time for her to focus on training. This will
include attending ongoing research seminars at Massachusetts General Hospital, meeting regularly with her
mentors, Dr. Huffman, Dr. Thorndike, Dr. Psaros, and Dr. Healy, and continuing to participate in the Harvard
Catalyst GRASP Program. She will also, as planned, take the three-day Blackburn Course in Obesity
Medicine, apply for the ORBIT Institute Developing Behavioral Treatments to Improve Health NIH-funded short
course in the spring of 2024, and will take an RCR refresher course.
Background. Metabolic/bariatric surgery is the most effective treatment available for severe obesity, yet about
25% of patients do not achieve sustained meaningful weight loss after surgery. Both adherence to health
behaviors such as physical activity and psychological well-being are associated with weight loss maintenance
after surgery, but up to 90% of patients do not meet physical activity recommendations post-surgery. A lack of
psychological well-being may contribute to low levels of physical activity, especially if patients have negative
emotional associations with physical activity. Interventions that consider this psychological component are
needed to improve physical activity adherence in patients after metabolic/bariatric surgery who are struggling
to exercise consistently.
Research Strategy. To address this gap, this K23 study is using a mixed methods design to adapt and test a
positive psychology-motivational interviewing physical activity intervention in patients post-surgery from the
Massachusetts General Hospital Weight Center. After completing qualitative interviews with 23 patients to
better understand emotional experiences related to physical activity and a proof-of-concept trial (N=12) of the
newly adapted intervention based on these interviews, a pilot randomized controlled trial is currently in
progress (target N=58) to test feasibility, acceptability, and preliminary efficacy of the intervention. The
proposed administrative supplement will allow this trial to continue to run efficiently during and after Dr. Feig’s
maternity leave to meet recruitment goals, laying the groundwork for an R01 application to test efficacy of the
intervention in a full-scale trial.

Public health relevance
PROJECT NARRATIVE Most patients after metabolic/bariatric surgery do not meet recommended levels of physical activity, which is critical to prevent weight regain and progression of chronic diseases. The proposed administrative supplement will allow for the timely continuation of a study that is developing and testing a 10-week remotely delivered positive emotion-based physical activity intervention for the unique needs of individuals with recent metabolic/bariatric surgery. If the intervention is successful, it has the potential to improve health outcomes and prevent chronic disease in this high-risk population.